Electronic Health Record-Based Dementia Prediction for HIV Primary Care

PROJECT SUMMARY
Jennifer Lam PhD, MPH is an infectious disease epidemiologist whose research focuses on improving the
health of the aging HIV population. Her prior research has explored the impact of chronic disease on persons
living with HIV. She has recently extended her work to the evaluation of dementia in the context of HIV
infection. Mounting evidence suggests that people aging with HIV experience a unique trajectory of cognitive
decline despite treatment with antiretroviral therapy. This may be due to the combined effects of HIV-mediated
inflammation and non-HIV factors such as substance use, psychiatric comorbidity, and cardiovascular disease.
As many people with HIV in the U.S. are now over 50 years old, age-associated dementias will become an
increasingly critical health concern. To date, few studies have characterized dementia in older individuals with
well-controlled HIV infection. The proposed research aims to: 1) quantify the contribution of sociodemographic,
behavioral, and comorbidity-related factors to risk of dementia in people aged 50+ years with HIV compared to
those without HIV, 2) develop and validate a model to predict incident dementia in people with HIV, using
electronic health record data and incorporating HIV-specific factors such as HIV infection severity and duration,
and 3) develop strategies to optimize the clinical utility of a dementia prediction model. A major strength of the
proposed research is that initial model development and validation will be conducted within a large healthcare
system with a well-characterized older population with HIV and stable, longitudinal follow-up. This will be
followed by validation in an external HIV cohort to assess generalizability, development of a prototype clinician-
facing risk stratification tool, and stakeholder interviews to obtain input on future clinical implementation. Novel
components of the research include characterization of dementia risk in a community-based sample of people
with HIV, comparison with HIV-uninfected individuals from the same setting, and use of advanced analytics to
evaluate multiple longitudinal predictors of dementia using primary care data in electronic health records. To
support the proposed research and Dr. Lam’s goal of future independent research in HIV and dementia, this
K01 proposal includes a formal, mentored training program to develop skills in: 1) the evaluation of risk factors
for neurocognitive disorders in people with HIV, 2) analytic modeling techniques for development and
validation of electronic health record data-based dementia prediction models, 3) translation and
implementation of research findings into clinical care settings, and 4) professional skills development. Trainings
will consist of coursework and tailored tutorials delivered by a mentorship team with combined expertise in HIV,
neurology, aging, biostatistics, and healthcare delivery science. The results of the proposed research will
inform strategies for dementia prevention in people with HIV and support plans to implement and test a
dementia risk stratification tool in clinical practice. It will also prepare Dr. Lam for a career as an independent
investigator conducting NIH-funded research on prevention and management of dementia in people with HIV.

Public health relevance
PROJECT NARRATIVE People living with HIV are at increased risk for developing dementia despite treatment with antiretroviral therapy. Dementia risk scores based on measures routinely collected in primary care may assist clinicians in identification of individuals who could benefit from earlier targeted intervention or cognitive screening. The proposed K01 Career Development Award will support Dr. Jennifer Lam in the completion of a mentored research project and acquisition of skills necessary for future independent research on the prevention and management of dementia in people with HIV.